Vet-LIRN Network Capacity-Building Project Molecular Gel Imaging system at UI VDL

Project Abstract
The University of Illinois (UI) Veterinary Diagnostic Laboratory (VDL) is a full service, AAVLD accredited, all
species, reference veterinary diagnostic laboratory. As a member of the VET-LIRN, UI VDL is one of the labs
actively involved in several VET-LIRN activities including iSeq-sequencing Listeria project as a lead lab,
providing isolates for MiSeq WGS sequencing project as a source lab, participation on antimicrobial resistance
pilot project, and evaluation of automatic nucleic acid extraction methods as a lead lab. The quality of gel images
for conventional molecular PCRs are critical in making call on the results and our current gel imaging system is
very old, thus producing low quality of images. In this proposal, we request funding to purchase a Bio-Rad
GelDoc Go Gel Imaging System to enhance UI VDL molecular service quality for testing animal diseases, and
routine case investigation and surveillance coordinated by Vet-LIRN.

Public health relevance
Public Health Relevance Statement: Project Narrative The molecular gel imaging system is critical to identification of pathogens and essential for the University of Illinois Veterinary Diagnostic Laboratory that currently uses a very old imaging system producing low quality of photos. Bio-Rad GelDoc Go Gel Imaging System would be useful for molecular diagnostic of food-borne pathogens in animals, safeguarding health of humans and animals.